DP21-001 Pregnancy Risk Assessment Monitoring System (PRAMS)

Project Abstract
The primary goal of the New York State Pregnancy Risk Assessment Monitoring
System (PRAMS) is to collect high quality population based data on maternal and infant
health that are not available from other sources. Data collected through the PRAMS
program will help New York State address several maternal and child health services
priorities identified in the state’s Prevention Agenda and in the Maternal and Child
Health Services Block Grant. PRAMS data provides important baseline information and
ongoing measures of New York’s progress in addressing maternal and child health
priorities.
A stratified random sample of women who have recently given birth to a live born
infant in New York State (excluding New York City) are sampled from birth certificate
records between 2-4 months after delivery and is stratified by birthweight
(<2500g/≥2500g). Approximately 140 women will be sampled on a monthly basis for a
yearly sample size of 1,600 for the next five years. PRAMS staff will work in conjunction
with the New York State Department of Health’s Bureau of Production Systems
Management and the Bureau of Biometrics and Health Statistics to ensure access to
birth files for PRAMS sampling. Mothers will be sent up to three questionnaire mailings
with telephone follow-up for non-responders.
Findings from the PRAMS analysis will be utilized and disseminated by the state’s
internal and external partners to monitor Prevention Agenda and Maternal and Child
Health priorities. In addition, PRAMS data will be disseminated via the PRAMS
Dashboard on the New York State Department of Health public web site to support
public health policy and program improvement. This site provides public access to
PRAMS data and is widely used by Health Department programs for evaluation and
assessment of ongoing DOH initiatives. The dashboard includes data on 64 indicators
with tables and trend graphs from 2004 – 2017.

Public health relevance
Project Narrative PRAMS data provides important baseline information and ongoing measures, that are not available from other sources of New York’s progress in addressing five of the nine priorities in maternal and child health such as access and barriers to prenatal care, oral health during pregnancy, low birthweight and infant mortality, substance abuse during pregnancy, unintended pregnancy and breastfeeding.